GENITAL FINDINGS IN ADOLESCENT GIRLS REFERRED FOR SEXUAL AB

Study utilizing the UCSD CDMAS facilities for data analysis of study of genital findings in adolescent girls referred for suspected sexual abuse.